From Risk to Resilience: Assessing Adverse Birth Outcome Risks and Adaptive Capacity to Fine Soil Dust and Heat Exposures in California

PROJECT SUMMARY
This K01 award will support the career development of Dr. Alexandra Heaney, a climate epidemiologist in the
Herbert Wertheim School of Public Health at UC San Diego. The candidate’s goal is to become a leader in
interdisciplinary research that combines cutting-edge causal inference and statistical modeling with community-
based mixed methods research to characterize the health impacts of climate-related environmental hazards
and to build community resilience to these hazards. This application proposes linked career development and
research activities to fill important gaps in knowledge surrounding the impacts of ambient dust and extreme
heat exposure on adverse birth outcomes. Extreme heat is an established risk factor for preterm birth (PTB)
and low birth weight (LBW), but knowledge of the impacts of mineral dust—a pollutant becoming more
prevalent in the Western US due to climate change—remains limited. Clarification of these environmental
factors' individual and combined effects on neonatal outcomes is needed. Further, local-level adaptive capacity
is integral to climate resilience, yet little work has investigated the lived experience of adapting to extreme heat
or dust exposures, especially among pregnant individuals. This project aims to advance the candidate’s
expertise and skills in environmental and perinatal epidemiological methods, dust exposure science, and
community engaged research to address these knowledge gaps. The candidate will leverage new modeled
concentrations of dust and a cohort of ~6.5 million mother-child pairs from the Study of Outcomes in Mothers
and Infants (SOMI) cohort to estimate the effects of dust exposure during pregnancy on PTB and LBW (Aim 1)
and quantify the interactive effects of dust and extreme heat exposures on adverse birth outcomes (Aim 2).
The candidate will then engage with community partners in Imperial Valley, CA where exposures to dust and
heat are particularly high, to examine the perceptions of risk, adaptive behaviors, and adaptation resources
used by members of the communities to mitigate the adverse impacts of these environmental hazards. The 3-
year plan includes mentorship from four experienced and committed faculty at UCSD with expertise in
community engaged and mixed-method research, perinatal epidemiology, and dust science. Two additional
mentors—leaders in environmental epidemiology and environmental health policy—will support the candidate.
Leadership of the proposed research, along with a training plan involving coursework, and mentored grant
writing, will advance the candidate’s training objectives to: 1); build expertise in dust exposure science 2); build
expertise in birth outcome research and perinatal and environmental epidemiological methods; 3) train in
mixed-method and community engaged research approaches; and 4) strengthen collaborative partnerships
and build leadership skills for directing transdisciplinary research projects. UCSD’s commitment to early career
scientists; leadership in implementation science, epidemiology, and climate science; and close community
partnerships will provide the candidate an outstanding environment to advance her career goals.

Public health relevance
PROJECT NARRATIVE As climate change drives increases in extreme heat and ambient dust exposures among populations in the Western US, it is critical to examine the as-of-yet poorly understood impacts of these environmental hazards on pregnant women and birth outcomes in this region. This project combines large-scale epidemiological studies with community-based mixed-method research to estimate the impacts of dust and extreme heat exposures on risk of preterm births and low birth weight in California, and to examine adaptive behaviors and resources used by vulnerable communities who are highly exposed and under-resourced. The findings will inform public health policies to mitigate risks and safeguard infant health, marking a significant step towards reducing environmental health disparities and enhancing community resilience to climate change.